Role of SIRT6 in the pancreatic beta cell aging

Project Summary
During aging, pancreatic beta cells undergo a decline in insulin secretion capacity, and this
contributes to nearly 3-fold high diabetes prevalence in people aged over 65 years compared to the
general population. Sirtuin 6 (SIRT6), a histone deacetylase, has been suggested to be a longevity factor.
In the preliminary study, we have demonstrated that SIRT6 is required to maintain normal beta cell
function and SIRT6 is downregulated in the beta cells during aging. Therefore, we hypothesize that SIRT6
plays an important role in the protection of pancreatic beta cells against aging-associated cellular
damage. In this application, we will investigate the SIRT6 function and mechanism in the regulation of
pancreatic beta cell aging. It is our expectation that the findings from this project will advance our
understanding of the fundamental process of the aging of pancreatic beta cells and provide potential
novel targets for the development of prevention and treatment of the age-related diabetes.

Public health relevance
Project Narrative The proposed research in this application is relevant to public health because better understanding of the regulatory mechanisms for pancreatic beta cell aging by sirtuin 6 is ultimately expected to provide a potential novel drug target for the prevention and treatment of the age-related diabetes. Thus, this project is highly relevant to the part of NIH’s mission that pertains to pursuing fundamental knowledge that will help to extend healthy life and reduce the burdens of illness.